CANCER CONTROL TECHNICAL DEVELOPMENT IN HEALTH AGENCIES

The Michigan Department of Public Health will, at end of the five year funding period, demonstrate the fundamental organizational and technical capacity, through the advice and assistance of a broad-based cancer coalition, to: 1. Plan, implement, and evaluate population-based cancer prevention and control programs in smoking cessation and prevention, early cervical cancer detection, and early breast cancer detection; 2. Identify and utilize needed technical cancer expertise from the local, state and national level; 3. Expand effective cancer programming into other cancer areas of high priority; 4. Translate proven cancer research findings into community practice; 5. Understand and apply state-of-the-art screening, diagnostic and therapeutic techniques for high priority cancer sites. 6. Assure the availability of state and local resources to support and sustain ongoing prevention and control efforts.